Molecular and Cellular Dynamics in Mammalian Signal Transduction

PROJECT SUMMARY
This MIRA proposal addresses two important avenues of discovery made by our laboratory. In
Project 1, we will examine a novel mechanism for allosteric regulation of the MAP kinase,
ERK2. This project advances the protein kinase field, by investigating in-depth how protein
motions underlie the activation of ERK and how this affects cellular responses to inhibitors of
this important enzyme. In Project 2, we will investigate a well-known observation that has never
been fully explained, that the responses of cells vary with the strength of ERK signaling. Project
2 advances the signaling field, by discovering and characterizing molecular and cellular events
controlled at different thresholds of ERK activity.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it dissects the mechanisms of action of molecules that go awry in cancer and other human diseases. The work in this proposal will examine previously unrecognized molecular processes which are central to the regulation of human cells. Detailed knowledge of these processes will provide information that can be used to develop new therapeutics to treat cancer and other diseases.